Harnessing implementation science to study stress management for correctional officers in jail settings

PROJECT SUMMARY
The purpose of this K01 Mentored Research Scientist Career Development award is to support Dr.
Margaret Gorvine's current trajectory toward independent investigator status—via achieving the study aims
and training goals to extend innovative research in the arenas of implementation science, integrative health,
and criminal justice. Dr. Gorvine is an Instructor/ Postdoctoral Fellow in the Department of Health Behavior and
Health Education in the College of Public Health, University of Arkansas for Medical Sciences (UAMS).
Jail incarceration rates in the United States have tripled since the 1980s. More than 3,100 jails
nationwide serviced 10.8 million jail admissions in 2018. Jail correctional officers (COs) are responsible for
maintaining security and supervising detainees in facilities that are often low-resourced (e.g. funding, staffing
shortages), are overcrowded, and replete with health risk exposures (e.g. Covid-19). Therefore, COs
experience high levels of stress due to violence and low autonomy. The high risk of adverse mental health
outcomes and health disparities among COs necessitates addressing CO stress management in jail settings.
The study will use an evidence-based quality improvement (EBQI) method to achieve the first 2 aims
including: 1) identifying barriers and facilitators to implementing a stress management intervention for
correctional officers in a jail setting through formative evaluation (e.g. in-depth qualitative interviews with key
jail stakeholders); 2) developing an implementation strategy package and intervention modifications. Thirdly,
conduct a pilot hybrid type II effectiveness-implementation trial of the stress management intervention for
correctional officers at the jail, measuring implementation outcomes of acceptability, appropriateness,
feasibility, and fidelity of the intervention and the implementation strategy package.
The training goals of the K01 Mentored Research Scientist Career Development award include: 1)
developing expertise in implementation research methods related to intervention delivery in jails; 2) enhance
skills in community-engaged research with partners within criminal justice settings; 3) learning how to build
community-engaged partnerships in the jail; 4) developing expertise in evidence-based mind-body intervention
delivery and research; and 5) Increase biostatistics expertise to be fully informed for in-depth collaboration with
biostatisticians.

Public health relevance
PROJECT NARRATIVE Jail correctional officers experience high stress exposure, adverse mental health outcomes, and health disparities which necessitates addressing CO stress management in jail settings. Using implementation science methods, this study will develop an implementation strategy package to deliver a stress management intervention in the jail. Subsequently, we will conduct a pilot hybrid type II effectiveness-implementation trial of the intervention and the implementation strategies measuring acceptability, appropriateness, feasibility, and fidelity.